Companion Animal and Animal Food Diagnostic Sample Analysis in Support of FDA Vet-LIRN Activities and Investigation.

PROJECT SUMMARY
The Clinical Infec�ous Disease Laboratory at the Mathew J Ryan Veterinary Hospital (PA-Ryan), located at the
University of Pennsylvania School of Veterinary Medicine, currently oﬀers comprehensive microbiology,
parasitology and molecular biology veterinary diagnos�c services for companion animal and exo�c species. PA-
Ryan became a member of the Veterinary Laboratory Inves�ga�on and Response Network (VetLIRN) in 2017. It
also is aﬃliated with the PADLS on the New Bolton Center campus, which is a ﬁrst- �er laboratory member of
the Vet-LIRN. PA-Ryan is experienced in the analysis of a variety of sample and matrix types, including but not
limited to animal samples, environmental samples, water, and animal food products. PA-Ryan is accredited by
the American Animal Hospital Associa�on (AAHA) as a hospital-based laboratory. In addi�on to addressing the
current need for added laboratory capacity in the event of a large-scale outbreak or threat incident involving
companion animals or animal food, PA-Ryan will con�nue to further strengthen the Vet-LIRN through molecular
diagnos�c ac�vi�es that beter enable early detec�on of emerging pathogenic agents and facilitate the rapid
responses that can minimize harm and best protect both human and animal health. In the previous 5 years
(FY2018-FY2023), the PA-Ryan lab has had several successes as a VetLIRN laboratory including publica�on of 5
peer-reviewed ar�cle, 4 public presenta�ons, 2 public webpages and 1 standardized protocol. PA-Ryan has also
expanded its capacity for tes�ng by implementa�on of new technologies and standardized tests with other
VetLIRN laboratories. PA-Ryan has also par�cipated in numerous VetLIRN proﬁciency tests and interlaboratory
comparison exercises. PA-Ryan currently serves as a Source Lab for the VetLIRN AMR surveillance project and
has provided 756 isolates for Whole Genome Sequencing during the previous funding period. During the next
funding period, PA-Ryan will con�nue to partner with VetLIRN to standardize methods and quality procedures
along with faithfully conduct VPO directed case inves�ga�ons and other projects. PA-Ryan is dedicated to the
mission the VetLIRN sets forth “to improve veterinary medicine and promote public and animal health”.

Public health relevance
PROJECT NARRATIVE The Microbiology lab at the Ryan Veterinary Hospital (PA-Ryan), located at the University of Pennsylvania School of Veterinary Medicine, currently oﬀers comprehensive microbiology and molecular biology veterinary diagnos�c services for companion animal and exo�c species. Over the past 5 years, PA-Ryan has been an ac�ve member of Vet-LIRN by expanding tes�ng op�ons and capacity, par�cipa�ng in mul�ple studies and proﬁciency/comparison exercises and developing methods. PA-Ryan serves companion animal veterinarians from the Commonwealth of Pennsylvania and throughout the United States making it an excellent ﬁt to con�nue as a VetLIRN laboratory.